Auto-calibrating, Air Quality Monitoring System

Auto-calibrating, Air Quality Monitoring System
Project Summary: In 2021 there were roughly 529,000 workers in the US chemical manufacturing industries,
and 226,840 “Extraction” workers in the U.S. oil & gas industry. With massive recent growth of the U.S. oil and
gas industries and anticipated future growth, worker exposures, to harmful levels of petrochemicals, are growing
and likely will increase. From 2003-2015, this industry reported 148 fatal injuries from exposures to “chemicals
and chemical products.” The effects of long-term exposure are not well tracked. In this Phase I SBIR Seacoast
Science, Inc. proposes to develop a fully automated system to support monitoring of indoor air quality (IAQ) in
the workplace. The proposed monitor combines a low-cost detector, twin trap-and-purge collectors, and the
separation and resolving power of gas chromatography to (1) collect and analyze air in its immediate
environment, (2) provide wirelessly networked data to industrial hygienists to track workplace exposure, (3)
reduce the per-sample analytical costs by automatically cycling between air sample collection, analysis, and
calibration, without user intervention. Remote programmability will provide unattended operation.
In this Phase I we will prototype an analyzer targeting occupational hazards such as benzene at least 10x
below OSHA action level (0.5ppm over 8-hr TWA) for the petrochemical industry. However, the system will be
modular, allowing for future customization other air-monitoring markets. Seacoast will integrate industry standard
thermal desorption (TD) tubes, selected from NIOSH and OSHA sampling and analytical methods with
appropriate materials for petrochemical hazards, into an oven-less resistively heated Mini GC system. The
system will cycle between tubes to provide uninterrupted monitoring, where sampling and analysis occurs in
parallel, increasing data throughput. We will select a chromatography column, specifically for high resolution
separation of BTEX (benzene, toluene, ethylbenzene, and xylene), and similar occupational hazards in and
around petrochemical industries, from interfering compounds. A high-sensitivity chemical detector –
photoionization (PID) – is selected for its high sensitivity to hydrocarbons and insensitivity to humidity and CO2.
A key feature of the proposed system is the development of auto-calibration and system purge validation.
Sub-systems and protocols will be integrated using an innovative manifold with dedicated sample loop to allow
the system to self-correct for detector drift and to detect impurities. The system will be inexpensive compared
to common in-laboratory analytical instruments (e. g. GC/MS), and portable for easy setup. At under $7,500, the
system's ability to provide data throughout a work shift, allows for a much lower cost per sample than the
traditional means of sample collection. At this price, air quality investigators can have an hourly or daily stream
of data, rather than weekly or monthly data. Seacoast will work with Markes International to validate the Phase
I prototype using their analytical labs, and with Viking Consultants to validate the market and develop protocols.

Public health relevance
PROJECT NARRATIVE This proposal describes a novel use of low-cost microsensors to develop a compact, system to help protect workers from inhalation exposure of harmful chemicals. Seacoast Science, Inc. is developing a system to track room air levels of vapor hazards, below OSHA action levels, and supporting use of OSHA standard methods. The analyzer will detect chemical vapors common to a wide range of high-risk occupations, including workers in the oil and gas, painting, metal working, and hazardous materials industries.